POP3 regulates type I interferon and ameliorates intestinal inflammation

Summary:
Inflammatory Bowel Disease (IBD) is a tremendous clinical problem, a life-long relapsing and remitting disease,
which also increases the susceptibility for colorectal cancer and for which no medical cure exists. IBD is an
inflammatory disease of the colon and the small intestine and includes Crohn’s disease (CD) and ulcerative
colitis (UC) with still poorly understood underlying pathologies. Therefore, defining novel molecular mechanisms
and pathways that protect or reduces the susceptibility of individuals from developing IBD is of high importance
and significant for developing novel therapies.
We originally discovered the PYRIN domain-only protein 3 (POP3), which is encoded in humans, but lacking
from mice, as a specific inhibitor of dsDNA and DNA virus-induced AIM2 inflammasomes in macrophages. We
now discovered that POP3 is expressed in a rare subset of human intestinal macrophages, but its expression is
significantly downregulated in the colon of CD and UC patients. Conversely, mice with transgenic POP3
expression in macrophages, including intestinal macrophages, are significantly protected from intestinal
inflammation in a mouse colitis model. Using genetic mapping, we identified that this effect is independent of its
known role regulating the AIM2 inflammasome, but that the POP3 protection requires type I interferon. Our
preliminary data further show that POP3 assembles into a novel nuclear signaling complex to promote a unique
type I interferon signature to shape the intestinal immune cell and microbiome composition.
The goal of this study is to determine the protective functional impact mediated by POP3 on intestinal
homeostasis and inflammatory disease, to elucidate the underlying molecular mechanisms focusing on a novel
POP3-containing nuclear protein complex that promotes type I interferon, and to identify and functionally
characterize the POP3+ intestinal macrophage cell type that protects from IBD. We expect that our research will
uncover novel protective molecular mechanisms, expand our knowledge on type I interferon signaling, and
identifies novel targets for future therapies to positively impact the quality of life of IBD patients.

Public health relevance
Narrative: More than 1.6m people in the US live with Inflammatory Bowel Disease (IBD), which is a tremendous clinical problem for which no medical cure exists, and its underlying pathology is still poorly understood. We discovered that our recently discovered POP3 protein is expressed in a subset of human intestinal macrophages, is downregulated in IBD patients and mice expressing POP3 in intestinal macrophages are protected from DSS- induced colitis, an IBD mouse model, and the goal of this study is to determine the details of this protection. Our mechanistic studies will elucidate the composition and function of a novel POP3-containing signaling complex leading to type I interferon production responsible for this protection, which can provide the basis for developing novel therapies to improve human intestinal health.